Clinical and Genetic Origins of Monomorphic Epitheliotropic Intestinal T Cell Lymphoma

ABSTRACT
Monomorphic epitheliotropic intestinal T-cell lymphoma (MEITL) is a rare but lethal disease with a median
survival of 1 year. There is no current effective standard-of-care. Previous MEITL sequencing efforts performed
by our group and others have revealed SETD2 as one of the most frequently altered genes in this disease.
SETD2 directs trimethylation of the lysine 36 residue on histone H3 (H3K36me3), which in turn is associated
with active transcription of genes. SETD2 has been implicated in DNA damage repair and mRNA splicing.
However, the molecular role of SETD2 and its interaction with activated oncogenes in MEITL pathogenesis is
largely unknown.
In this proposal, we will utilize a conditional mouse model to determine how SETD2 loss contributes to the
creation of a premalignant pool of intestinal intraepithelial cells (IELs), the cell of origin of MEITL. We will also
investigate how the combination of SETD2 loss and activation of the oncogenes STAT5B or MYC lead to IEL
transformation. Finally, we will determine the extent to which SETD2 deficiency sensitizes T lymphoma cells to
a variety of genotoxic chemotherapeutics. We anticipate that the results of this work will have immediate impact
on the design of effective treatment regimens that target MEITL and other SETD2-deficient lymphomas.

Public health relevance
PROJECT NARRATIVE Monomorphic epitheliotropic intestinal T-cell lymphoma (MEITL) is a rare but lethal disease with a median survival of 1 year. The molecular role of SETD2 (the most frequently silenced gene in MEITL) and its interaction with activated oncogenes in MEITL pathogenesis is largely unknown. In this proposal, we develop novel mouse models of this disease to define the role of SETD2 in MEITL pathogenesis.